A Double-Blind, Randomized, Controlled Trial of Epidural Conus Medullaris Stimulation to Alleviate Pain and Augment Rehabilitation in Patients with Subacute Thoracic Spinal Cord Injury (SCI)

ABSTRACT
Spinal Cord Injury (SCI) represents a significant unmet need, posing a tremendous health and economic
challenge for patients and society. Pain is a common complaint among people affected by SCI, and its
persistence negatively impacts their quality of life (QOL). Approximately 65–85% of patients with SCI suffer
from pain, and one-third of these characterize the pain as severe. While some treatments reduce the severity
of pain in some individuals, no treatments that are currently available consistently relieve pain in the SCI
chronic pain population. Persistent pain is one of the consequences of SCI that has consistently been shown to
significantly decrease perceived quality of life (QOL). Pain interferes with sleep, cognitive, emotional, and
physical health and functioning. Pain relief has been identified as one of the highest areas of unmet needs in a
recent study of 1,000 individuals with SCI. Epidural Electrical Stimulation (EES), also known as Spinal Cord
Stimulation in (SCS), is a common FDA-approved therapy for chronic neuropathic pain of trunk and limb.
Recent studies have demonstrated the ability of EES to augment motor recovery in SCI rehabilitation. EES of
spinal elements distal to a lesion has demonstrated previously untapped rehabilitative potential in patients with
‘complete’ SCIs. We propose a double-blind, prospective, randomized clinical trial where patients with
subacute, traumatic, complete thoracic SCIs with American Spinal Injury Association (ASIA) Impairment Scale
A are randomized to receive either “EES on” (treatment) or “EES off” (control) of the target regions for pain
control (lead overlying the spinal cord anatomy corresponding with their pain distribution) and neurorestoration
(lead overlying the conus medullaris) as an adjunct to physical therapy (PT). The objective of this study is to
examine the feasibility of EES on improving pain and rehabilitation outcomes in patients with SCI. We
hypothesize that patients who receive EES will outperform their counterparts in the control group in pain and
exploratory endpoints including motor, sensory, bladder and QOL outcomes. We also hypothesize that when
the control group crosses over to late stimulation, they will show improvement on a lesser scale than the early
intervention group, but that these patients will also show significant improvement compared to their own control
period. We propose the following Aims: Aim 1 will compare the impact of EES on pain and QOL in patients
with SCI between control and placebo groups, using the SCI version of the Multidimensional Pain Inventory
(MPI-SCI); Aim 2 will compare motor recovery as assessed by EMG and dynamometry between intervention
and control groups at up to 9-months, followed by a second comparison of unblinded early versus late
stimulation for another 9-month period; Aim 3 will compare the impact of EES on sensory, bladder and quality-
of-life in patients with SCI between intervention and control groups, outcomes. Impact: If successful, this
HEAL project would help determine whether this well-established clinical intervention can help patients with
SCI neuropathic pain and have more widespread clinical applicability.

Public health relevance
NARRATIVE Duke will serve as a UH3 HEAL Research Site and conduct a “Double-Blind, Randomized, Controlled Trial of Epidural Conus Medullaris Stimulation to Alleviate Pain and Augment Rehabilitation in Patients with Subacute Thoracic Spinal Cord Injury (SCI).” This project will provide strong evidence for an FDA-approved, non-opiate therapy to specifically improve pain associated with SCI as well as potentially also impact motor, sensory and bladder function. The overall goal of this intervention is to improve pain and quality of life of patients with SCI.